Genes and Nutrition: Dietary Choline, the Gut Microbiota, and Atrial Fibrillation

Summary:
Atrial fibrillation (AF) is multifactorial and acquired factors, such as obesity, alcohol abuse, and heart failure,
contribute to its pathogenesis. Moreover, despite the use of anticoagulants to prevent left atrial thrombosis,
patients with AF are still at risk for ischemic stroke or the complications of anticoagulation. Our inability to
manage AF with available tools emphasizes the critical need to search for novel treatment pathways that target
its underlying mechanisms. Over the past several years the gut microbiome has been linked to atherosclerotic
disease by gut microbiota catabolism of dietary choline to trimethylamine (TMA) which is further oxidized in the
liver by flavin monooxygenase to trimethylamine N-oxide (TMAO). Elevated plasma TMAO levels
independently predict major adverse cardiovascular events (MACE) and have been mechanistically linked to
atherosclerotic disease by (i) increasing endothelial inflammation by priming and activating the NOD-, LRR-
and pyrin domain-containing 3 (NLRP3) inflammasome by the production of mitochondrial reactive oxygen
species, (ii) increasing adiposity by regulating white adipose tissue, and (iii) enhancing thrombosis by
activating platelets. The NLRP3 inflammasome has been linked to the pathogenesis of AF in animal models,
obesity is a major risk factor for AF, and enhancement of thrombosis by TMAO may increase AF patients’
susceptibility to stroke. We have gathered preliminary data demonstrating that (i)TMAO independently
associates with prevalent and incident AF, (ii)TMAO may prime the NLRP3 inflammasome in atrial-like induced
pluripotent stem cell-derived cardiomyocytes (a-iCMs), (iii) TMAO blunts the atrial action potential in ex vivo
mouse hearts in a gut microbiota dependent manner, and (iv) TMAO reduces the resting potential and
shortens the duration and decreases the peak amplitude of the action potential in a-iCMS. These data suggest
TMAO may be involved in the pathogenesis of AF by causing metabolic and electrophysiological dysfunction in
cardiomyocytes, thereby promoting AF. In this project, we propose to investigate the mechanisms underlying
the association of TMAO and the gut microbiome with AF. Aim 1 will investigate the role of the gut microbiome
in AF susceptibility. We will first suppress the entire gut microbiota with broad spectrum antibiotics using AF
susceptible mice on and off a choline diet and monitor for the progression of AF. We then will use a pathway
specific inhibitor, fluoromethylcholine (FMC), to demonstrate that choline metabolism to TMAO is specifically
promoting AF. In a final set of studies, we will confirm the role of the gut microbiota in AF by performing fecal
transplants to determine if susceptibility to AF is a transmissible trait. The second aim will investigate
mechanisms by which TMAO promote AF. The first subaim will explore the role of the NLRP3 inflammasome in
the TMAO-promoted susceptibility to AF, fibrosis, and left atrial thrombosis. The second sub aim will explore
the role of TMAO in causing electrophysiological dysfunction in ex vivo mouse atrial studies and in atrial
engineered heart tissue. Together these studies may link together the diet, the gut microbiome, and AF.